Effects of tACS on alcohol-induced cognitive and neurochemical deficits

ABSTRACT: Alcohol is one of the most widely used drugs by adolescents and is often consumed in a binge
drinking pattern. Binge drinking alcohol during this critical developmental period can lead to lasting cognitive
impairments for which there are few effective treatments. One domain that is disrupted following adolescent
binge alcohol use is behavioral flexibility, defined as the ability to adapt behavior to a changing environment. The
neurocircuitry underlying behavioral flexibility is complex but includes the medial prefrontal cortex (mPFC), the
orbitofrontal cortex (OFC), and the anterior insula cortex (aIC), all regions that are among those perturbed by
adolescent alcohol use. To better understand the neural mechanisms underlying adolescent alcohol induced
cognitive impairments and to test novel treatment paradigms, our lab utilizes a rat model of adolescent binge
alcohol exposure (adolescent intermittent exposure, or AIE). We have identified deficits in behavioral flexibility
as measured by an attentional set shifting task in AIE-exposed rats compared to controls. Furthermore, we have
recently identified AIE-induced changes in perineuronal nets (PNNs), a component of the extracellular matrix
that preferentially forms around parvalbumin (PV) interneurons and modulates their activity. AIE was shown to
increase PNN density in the mPFC and OFC, and a higher proportion of PV+ interneurons were surrounded by
PNNs. Additionally, we have collected preliminary data suggesting that AIE leads to a higher proportion of PV+
interneurons surrounded by PNNs in the aIC. As these altered neurochemical markers are found in the mPFC,
OFC, and aIC, they may underpin the observed deficits in behavioral flexibility following AIE. One potential
strategy to improve deficits in behavioral flexibility is by using transcranial alternating current stimulation (tACS),
a noninvasive neuromodulatory technique used in humans. tACS has been reverse translated and has been
shown to restore flexible behavior in rats that have drug-induced impairments. Further, tACS is known to alter
gamma oscillations, which are regulated by PV interneurons. However, it is not known whether tACS treatment
will restore adolescent alcohol-induced deficits in behavioral flexibility. Additionally, it is currently unknown
whether tACS can alter neurochemical markers. This F32 proposal will: 1) determine if tACS treatment
normalizes PNN density in adult AIE-exposed rats; and 2) determine if tACS treatment restores alcohol-induced
deficits in behavioral flexibility. Clinically, these studies will be impactful because they test the ability of tACS to
ameliorate alcohol-induced deficits in behavioral flexibility, something known to be disrupted in humans following
adolescent binge-alcohol consumption. The results generated from these Aims will lay the necessary
groundwork for future investigations and grant proposals, such as a K99/R00 application. Completion of the
proposed study will allow me to be trained in a highly clinically relevant technique (tACS), as well as expand my
expertise in immunohistochemistry and behavior, and by doing so, prepare me to address important questions
in the field of alcohol research as I progress towards my goal of becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE Alcohol exposure during adolescence leads to lasting behavioral flexibility impairments and neurochemical changes, for which there are few effective treatments. Transcranial alternating current stimulation (tACS), a noninvasive neuromodulatory technique used in humans, has been shown to alter cognitive behavioral measures. The proposed aims seek to determine if tACS is able to restore alcohol-induced deficits in behavioral flexibility in adolescent alcohol-exposed rats and will begin to elucidate potential mechanisms by assessing its effects on neurochemical markers.